COMMUNITY BASED MEDIA PREVENTION CAMPAIGN

The goal is to develop, produce and implement media campaigns that will help in prevention of drug use in smaller communities where local resources are limited. A local survey is given to assess adolescent drug use. The results will provide input for computer programs that produce media materials for a year-long campaign including: newspaper articles; pamphlets; visuals and outlines for presentations to community organizations, parent groups and service groups; newspaper ads; billboards; radio spots; posters; and a Community Media Action Manual. All media messages will include local data and local references. The impact will be tested in a true experiment using communities as the unit of analysis with blocking and random assignment of communities. The media campaign will be aimed at changing drug use and the following attitudes: (1) intent to use, (2) perceived harm, (3) perceived parental sanctions against drugs, (4) peer encouragement to use drugs, (5) peer sanctions against drug use, and (6) perceived parent/child communication about drug involvement in 8th, 10th and 12th graders.